Profiling and forecasting individual unique progression in ADRD using machine learning

PROJECT SUMMARY
Alzheimer's disease and related dementias (ADRD) are progressive disorders that can begin over 20 years
before symptoms appear. However, less than 50% of patients are diagnosed accurately in the early stage. Early
and accurate detection of ADRD is critical for timely intervention but is extremely difficult due to the large
heterogeneity among patients. No single diagnostic or prognostic tool is sufficient to fully explain the
heterogeneity of ADRD. Relying solely on a single modality restricts our grasp of the complex dynamics at play
within ADRD, significantly reducing diagnostic and prognostic capabilities in our current care settings. The overall
goal of this project is to address this critical unmet need through the proposed research and mentored training
of the applicant. The scientific goals of this proposal are to 1) deploy a multi-modal information framework that
leverages decades-long in vivo and digital biomarkers, 2) profile the inter-individual heterogeneity of ADRD, and
3) build a risk prediction model of time-to-diagnosis from machine learning and time series analysis. The
applicant will generate digital biomarkers collected through passive infrared motion sensors, wearables, sleep
mats, electronic scales, computer usage software, and weekly online questionnaires. The applicant will establish
acoustic and linguistic markers from semi-interview conversation recordings. In addition, the applicant will
process in vivo biomarker data such as plasma, cerebrospinal fluid, and neuroimaging data. Such multi-site,
multi-factorial data will be used to classify subtypes of ADRD and predict time-to-diagnosis. In order to conduct
the proposed study and prepare for an independent research career, the applicant will be trained through taking
courses and attending conferences in the following areas: 1) the underlying neurodegenerative processes
related to ADRD, with a specific focus on the utilization of in vivo biomarkers in research; 2) methods of using
technology and digital biomarkers in dementia research; 3) methods of deep learning and time series analysis
for building risk prediction models of time-to-diagnosis; and 4) development of professional skills for conducting
successful and ethically responsible clinical research. The proposed team of mentors each provide expertise in
one or more of these areas and are together committed to collaboratively facilitating the applicant’s training. The
applicant will apply these new skills to the proposed research project and obtain R01 or equivalent support to
use the methods for improving the diagnostic capabilities in current care settings. Such findings are likely to
make significant advances in reshaping personalized dementia care for millions of people.

Public health relevance
PROJECT NARRATIVE Early and accurate detection of ADRD is critical for timely intervention but is prohibitively difficult due to the large heterogeneity among patients. No single diagnostic or prognostic tool is sufficient to fully explain the heterogeneity of ADRD. To address this gap, the research and training for this Mentored Quantitative Research Development Award will be centered on deploying a multi-modal information framework that integrates in vivo and digital biomarkers sourced from existing longitudinal studies to improve diagnostic and prognostic capabilities of ADRD.